CRITICAL ASSESSMENT OF CHELATION THERAPY FOR CHILDHOOD LEAD INTOXICATION

To assess, in a controlled fashion, the clinical pharmacology of the three available chelating agents, in relation to the body removal of lead.